Systematically screening and validating drug repurposing candidates for Alzheimer's Disease and Related Dementias

Alzheimer's Disease and Related Dementias (AD/ADRD) are common progressive conditions that
damage critical mental functions, causing significant emotional, physical, and financial burdens.
Currently, there is no cure for AD/ADRD, nor a drug to delay the onset of the disease. New drugs
targeting AD/ADRD have had a 99% failure rate, largely attributable to incomplete biological
knowledge, an emphasis on testing single therapies, a lack of predictive validity in animal models,
and unacceptable adverse effects. Drug repurposing--identifying new uses for existing drugs--
offers an alternative approach that can reduce the time, costs, and risks of failure associated with
new drug development. Indeed, genetic research and large biobanks have accumulated a wealth
of relevant data for AD/ADRD drug repurposing efforts. However, given the complexity of
AD/ADRD pathogenesis, standard efforts to identify and prioritize drug repurposing candidates
for downstream analyses have not yielded success; these repurposing efforts generally arise from
basic science or clinical observation and result in a one-at-a-time approach focused on candidate
validation in clinical trials. Such efforts ignore the opportunities provided by big data (e.g., genetics
and electronic health records) for identifying and validating candidates. The lack of standardized
approaches to systematically screen and validate drug repurposing candidates represents a
critical barrier to the success of leveraging existing public knowledge and clinical data to advance
AD/ADRD treatment. We propose integrating genetics, transcriptomics, literature, and clinical
data with advanced informatic technologies and computational capabilities to develop and share
tools which systematically screen, prioritize, and validate drug repurposing candidates and their
combinations for AD/ADRD. The proposal responds to PAR-22-093, incorporating several
emphases highlighted in related notices of interest (e.g., NOT-AG-21-045, NOT-AG-21-033, and
NOT-AG-21-050). In Aim 1, we will systematically screen and prioritize drug repurposing
candidates for AD/ADRD via both virtual transcriptome and Mendelian randomization, validating
the candidates in multiple large clinical datasets. In Aim 2, we will identify, assess, and validate
candidates from the literature. In Aim 3, we will evaluate and validate combinations of drug
repurposing candidates. For all validations, we will assess the candidate drug/drug pair’s benefits
for prevention (i.e., pre-morbidity exposure) and treatment (i.e., post-morbidity exposure),
including analyses stratified by dose, gender, and race. In Aim 4, we will make our findings,
including deployable tools and codes, broadly available on the AD Knowledge Portal and related
websites to facilitate future research.

Public health relevance
New drugs developed to target Alzheimer's Disease and Related Dementias (AD/ADRD) have a 99% failure rate; however, drug repurposing--identifying new uses for existing drugs--offers an alternative approach that can reduce the time, costs, and risks of failure associated with new drug development. The lack of systematic and readily deployable approaches to screen and validate drug repurposing candidates represents a critical barrier to the success of leveraging existing public knowledge and clinical data for the advancement of AD/ADRD treatment and prevention. We propose combining big data with advanced informatic technologies and computational capabilities to develop and share tools which systematically screen, prioritize, and validate drug repurposing candidates and their combinations for AD/ADRD.